Development Core

PROJECT SUMMARY/ABSTRACT (DEVELOPMENT CORE)
Ending the TB epidemic requires a multifaceted approach which spans basic science discovery, data science,
epidemiology, clinical trials, and implementation. To discover and apply solutions, highly trained and skilled TB
experts are required to create data-driven strategies that are effectively implemented. The primary goal of the
Development Core is to recruit, train, and support a vibrant cadre of TB scientists who will provide high impact
leadership with major contributions to ending the epidemic. The Development Core will focus on new
investigators (NIs) at the start of their careers and more established scientists who are new to TB research.
The TRAC Developmental Core will work closely with other SEA-TRAC Cores to address knowledge gaps by
building on the initial efforts and success of the UW TB Research and Training Center (TRTC). Specifically, this
will include expansion of existing programs and newly designed initiatives to foster the development of the next
generation of scientists who will be world leaders in ending the TB epidemic.
In Aim 1, we focus on the early TB training pipeline by recruiting new trainees in TB research and develop leaders
who will impact the TB epidemic launching a new TB Undergraduate Program (TBUP), expand our recently
developed TB Scholars Program (TBSP), which supports undergraduate research and training for trainees
belonging to historically underrepresented minority groups and develop a new TB Leadership Program (TBLP)
for new investigators (graduate and post-doctoral level) to foster their transition to independence. In Aim 2, we
develop and integrate curricular opportunities with the Clinical and Translational Science, Basic Science, and
Data Science Cores with workshops (including manuscript writing and mock NIH grant review), courses, and
monthly seminar series, that will provide high quality TB content and incorporate UW E-learning initiative and
remote learning to increase accessibility to a broad cadre of learners. In Aim 3, we will fund catalytic
developmental project awards to generate momentum through preliminary data and support new directions for
use in larger independently funded grant submissions. This will include opportunities focused on new
investigators (NI) through New Investigator Awards (NIAs) and more established investigators entering TB
research through New to TB awards (N2TBs). We will also provide funding for awardees to disseminate their
results through publication or presentation at scientific meetings via Awardee Support Grants (ASG). Together,
these efforts will foster the development of the next generation of scientists who will be world leaders in ending
the TB epidemic.